Autophagy and Arteriovenous Fistula Maturation

The vascular access is the lifeline for the hemodialysis patient and the single most important
component of the hemodialysis procedure. The most common etiology of vascular access
dysfunction in hemodialysis patients is failure of an arteriovenous fistula (AVF) to mature
successfully for dialysis use (AVF maturation failure). At present, there remains a very high rate of
AVF maturation failure in the United States and there are no effective treatments to enhance AVF
maturation. On a radiologic level, AVF maturation failure is most commonly characterized by a
stenosis at the venous anastomosis, and at a histological level it is characterized by a combination
of aggressive intimal hyperplasia and poor outward remodeling. The poor outcomes following AVF
creation reflect our limited understanding of the mechanisms leading to AVF maturation failure; and
the lack of therapies to treat this clinical problem represent an unmet clinical need. The objective of
this proposal is to investigate a new paradigm, the role of autophagy in AVF maturation. Our
proposal is novel and supported by strong preliminary work from our research team pointing to a
causal role for repressed endothelial cell (EC) autophagy in AVF maturation failure, in response to
a unique setting of disturbed hemodynamics in the AVF and chronic kidney disease (CKD) milieu.
Based on these preliminary studies, the central hypothesis of this proposal is that disturbed flow
and CKD repress endothelial autophagy, leading to AVF maturation failure. Using a combination of
in vitro, in vivo, and, human studies, we will test our central hypothesis with three specific aims: (1)
Identify steps of EC autophagy repression in the setting of disturbed flow and CKD milieu, (2) Define
how repressed EC autophagy contributes to AVF remodeling, and (3) Determine the role of
autophagy in AVF maturation in hemodialysis patients. We believe our proposed research is
significant because: (1) it addressed a very important clinical problem in hemodialysis patients, AVF
maturation failure, where there are presently no effective therapies; and (2) examine a new
paradigm in AVF development, autophagy. Successful completion of these aims will identify
important targets for developing innovative therapies that aim to modify autophagy in order to
enhance AVF maturation.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because sixty percent of arteriovenous fistulas created in hemodialysis patients in the United States fail to mature for successful use on hemodialysis. Improving the understanding of the pathogenesis of arteriovenous fistula maturation failure will lead to development of new therapies to treat this important clinical problem, and will help reduce the use of hemodialysis catheters. Thus, the proposed research is relevant to the part of the NIH’s mission that pertains to developing fundamental knowledge to help reduce morbidity and mortality for patients on hemodialysis requiring a vascular access.